HBV-specific T cell immunity in HBV/HIV coinfection

Project Summary/Abstract
Among people living with HIV (PLWH), hepatitis B virus (HBV) is a common coinfection that contributes to high
rates of liver-related mortality. Even with early initiation of antiretroviral therapies that include HBV-active
nucleoside analogs (NA), mortality in people with HBV/HIV coinfection remains unacceptably high. There is a
strong rationale for additional HBV therapies for people with HBV/HIV infection. The HBV cure research agenda
is to (1) understand HBV biology, particularly the mechanisms that lead to HBV functional cure (FC), which is
defined as seroclearance of the hepatitis B surface antigen in blood, and (2) to evaluate novel antiviral and/or
immunotherapies that can increase HBV FC from its current rate of ~1% per year. However, at the present,
PLWH are poorly represented in HBV cure research, and HIV infection is an exclusion criterion in virtually all
clinical trials of novel HBV therapeutics. To accelerate the use of novel therapies in patients with HBV/HIV
coinfection, a better understanding is needed of host control of HBV in the setting of HIV. This project focuses
on cellular immune mechanisms of HBV control, particularly HBV-specific T cells. Our central hypothesis is that
in HBV/HIV coinfection, CD4 T cells represent a critical component of the immune response mediating HBV
control, including FC. This hypothesis will be tested through 3 specific aims. In Aim 1, we will investigate the
impact of HIV coinfection-associated immune dysregulation, especially CD4 depletion, on the quantity and
quality of HBV-specific T cell responses. In Aim 2, we will investigate the T-cell responses mediating HBV FC in
patients with HBV/HIV coinfection who are treated during inactive HBV infection (i.e., low HBV DNA, normal ALT,
no-minimal liver disease). In this group, we previously reported relatively high rates of HBV FC. In Aim 3, we will
characterize the evolution of HBV-specific T cell responses and the intrahepatic immune landscape during adult
acute HBV infection that typically results in HBV FC, with and without HIV coinfection. The above scientific
investigation will occur within a unique HBV clinical cohort in Zambia (Southern Africa), which includes adult
patients with chronic and acute HBV infection, with and without HIV coinfection, and features longitudinal large
volume blood and liver sampling before and during NA therapy. To date HBV FC has been ascertained >40
times in the cohort, mainly in participants with HBV/HIV coinfection. Successful completion of this project will
change the field by identifying immune mediators associated with HBV FC in HBV/HIV coinfection and by defining
specific immunological barriers to HBV FC in PLWH. It also will help to identify patient groups with coinfection
who may be more or less amenable to cure with emerging drugs based on their current or nadir CD4 and current
level of HBV control. In-depth analysis of specific CD4 T cells and the intrahepatic immune milieu will also be
highly significant in our understanding of chronic HBV infection without HIV.

Public health relevance
PROJECT NARRATIVE The hepatitis B virus (HBV) cure agenda is focused on translating knowledge around viral-host interactions to effective new therapies or combinations of therapies that increase the frequency of functional cure. To accelerate the use of emerging cure therapies in people with HBV/HIV coinfection, a precise understanding of the impact of HIV on host control of HBV is needed. Leveraging a well-established hepatitis B research program in Zambia, and unique expertise in the analysis of HBV-specific immunity, we will investigate the role of specific CD4 T cells in the development of HBV functional cure in people with HIV.